Short-term estradiol use in middle-age: implications for female cognitive aging

Summary
Loss of ovarian hormones during menopause coincides with cognitive decline and increased risk of
Alzheimer's disease and related dementias. Due to putative health risks associated with prolonged exposure to
estrogens, current guidelines recommend limiting hormone therapy to a few years to treat menopausal
symptoms. Work from our lab in rodent models of menopause has demonstrated long-lasting benefits of short-
term midlife estradiol treatment on hippocampal function and memory through sustained activation of estrogen
receptor (ER) α that are likely permanent, persisting long after the estradiol treatment is terminated. These
findings correspond with evidence across multiple species, including humans, that elevated levels of brain ERα
are associated with enhanced cognitive aging even in the absence of circulating estrogens. Mechanisms by
which increased levels of brain ERα enhance cognitive aging in females with a history of previous midlife
estradiol treatment is the broad focus of the current research. The overall hypothesis to be tested by the
current studies is that a short-term period of midlife estradiol treatment reverses the negative impact of long-
term hormone deprivation on hippocampal function by sustaining levels of brain-derived or neuroestrogens well
beyond the period of estradiol treatment. Sustained levels of neuroestrogens allows for insulin-like growth
factor-1 (IGF-1) mediated activation of the ERK/MAPK signaling pathway to predominate over the PI3K/Akt
pathway, which in turns allows for sustained, continued activation of ERα and subsequent regulation of ERα-
mediated genes and proteins important for memory. Guided by supporting data, this hypothesis will be tested
by three aims. In Aim 1, we will use a transgenic mouse model that allows for Cre-dependent site-specific
inactivation of ERK signaling to determine its role in the ability of IGF-1 to activate ERα and ERα-regulated
genes and proteins and impact memory. In Aim 2, we will use transgenic mouse models and viral vector
delivery of ERα to manipulate ERK and ERα signaling to determine the respective roles of ERK and ERα in the
ability of midlife estradiol exposure to impact hippocampal neuroestrogen synthesis long-term. In Aim 3, we will
use pharmacological manipulations to determine if the detrimental effects of long-term ovarian hormone
deprivation on the hippocampus and cognition can be reversed by altering the balance of IGF-1 mediated
signaling from PI3K/Akt to ERK/MAPK. Completion of the proposed aims is expected to have a positive impact
on the study of cognitive aging by elucidating mechanisms by which the postmenopausal cognitive aging
trajectory can be enhanced, results that have implications for preventing or delaying onset of Alzheimer's
disease and related dementias.

Public health relevance
Project Narrative As the population of the United States ages, increased incidence of age-associated dementias including Alzheimer's disease will become a major public health issue. Interventions that could delay the onset of cognitive decline would have a major public health impact. These studies will help determine mechanisms by which short-term administration of estrogens near the time of menopause could exert lasting benefits to the cognitive health of women as they age.